Advanced microscope technologies for single-molecule functional analyses of stereocilia components necessary for normal human hearing

Project Summary/Abstract
Sensorineural hearing loss affects 20% of the population in the United States at all ages. A normal acoustic
sense requires a variety of cells in the inner ear, in the brain and on neuronal pathways. In the inner ear,
stereocilia on the apical surface of hair cells function as biological mechanical switches, and their degeneration
is one of the causes of sensorineural hearing loss. Presently, there are no clinically useful treatments to
regenerate or repair damaged stereocilia. In this K99 proposal, I describe my ongoing and future studies using
single-molecule microscopy techniques (1) in live hair cells and (2) in stereocilia F-actin cores. I am also
developing (3) a novel mouse line to visualize the developmental transition of nascent microvilli to mature
stereocilia and to identify novel candidate “deafness genes”. Single-molecule microscopy in live hair cells has
already yielded a novel model to explain the molecular dynamics in stereocilia and succeeded in detecting
abnormal kinetics of mutant molecules. With these techniques, I introduce the concept of “single-molecule
functional analysis” to hearing research and analyze the functions of “deafness gene” variants discovered in
families segregating hearing loss. The training objective in this K99 award is to develop novel microscope
methodologies. Specifically, I will develop single-molecule microscopy in live stereocilia by learning diSPIM
light-sheet microscopy and new ways of high-resolution imaging using deep learning from Dr. Hari Shroff
(NIBIB/NIH), my co-mentor, who is a world-renowned engineer of novel microscopes. I will learn cryo-electron
microscopy (CryoET) from Dr. Dennis C. Winkler (NIDCD/NIH) to localize single molecules in F-actin cores
and STED super-resolution microscopy from Dr. Christian A. Combs (NHLBI/NIH) to visualize the change of
molecular dynamics using my novel mouse models that I am establishing in the laboratory of my NIDCD/NIH
mentor, Dr. Thomas B. Friedman. The research aims during the mentored (K99) phase are to elucidate the
molecular dynamics of stereocilia components using these advanced microscope techniques. Single-molecule
microscopy in live stereocilia will visualize dynamics over the short time span of seconds to minutes. Two other
techniques, CryoET and STED in combination with our novel mouse line, will elucidate dynamics over a longer
time span during repair processes and development. Molecular dynamics elucidated by these techniques will
be a control to detect abnormal functions of “deafness gene” variants as I provide in the preliminary data
section. The aim during the independent (R00) phase is to identify and study candidate “deafness genes” and
potential therapeutic targets for human deafness. I will use my novel mouse model to study the cessation of
treadmilling during the transition of microvilli to stereocilia. By combining transcriptomics, I will identify
molecules localized in microvilli which have ceased normal F-actin treadmilling as they transit to nascent
stereocilia. With these microscopy techniques, I will (1) establish a pipeline to analyze functions of stereocilia
molecular components and (2) reveal therapeutic targets for sensorineural hearing loss.

Public health relevance
Project Narrative Sensorineural hearing loss is a common disease with a prevalence of 20% in the United States, which can impede development of speech and language skills in children and cognitive functions in adults. Stereocilia of inner ear hair cells are organelles that function as biological mechanical switches essential for normal hearing and often degenerate in individuals with sensorineural hearing loss. Single-molecule functional analyses proposed in this study are experimental frameworks to elucidate the molecular dynamics in wild type stereocilia with the goal of identifying therapeutic targets for malfunctioning stereocilia.